MULTICENTER STUDY OF CYCLOSPORINE IN THE TREATMENT OF ADULT NEPHROPATHY

Compare six months treatment course of cyclosporine plus low dose predinose vs. placebo plus prednisone in patients with focal segmental glomerulosclerosis or membranous glorulonephritis and persistent nephrotic range proteinuria.